Testing a Multilevel, Multicomponent, Multigenerational Dietary Intervention to Improve Southeast Asian Children's Diets

Background. Poor diet quality is a significant and critical problem for Southeast Asian (SEA) children whose
families came to the US as refugees [e.g., Hmong, Cambodian, Laotian, Vietnamese]. SEA children are
disproportionately burdened by higher rates of obesity and increased risk of other diet-related chronic diseases
like type 2 diabetes relative to other Asian subgroups, Whites and “Other” races. Although dietary interventions
have been shown to prevent/delay onset of diet-related chronic diseases, to our knowledge, there are no
dietary interventions developed specifically for SEA children. Thus, there is an urgent need for dietary
interventions that leverage state-of-the-art methods to address existing health disparities affecting SEA
children and to advance scientific understanding of gaps in intervention research. Overview of Proposal. This
proposal reflects our eight year (ongoing) academic-community research partnership with the Center for SEA
in Rhode Island, formative work with SEA families, and our extensive experience conducting successful dietary
interventions with underserved health disparity groups. The current study is a pilot feasibility study that tests an
innovative multilevel, multicomponent, multigenerational dietary intervention to improve diet quality among SEA
children. Conceptual Model. The Community Energy Balance and Family-Centered Action Model of
Intervention Layout and Implementation frameworks provide the intervention rationale and structure. These
frameworks propose that for disparity ethnic minority groups like SEA, multilevel, multicomponent,
intergenerational interventions are the most effective intervention approach for changing and sustaining
individual-level behavior change. Social cognitive theory and popular education philosophy inform the
intervention content. Overview of Research Plan. 75 SEA families with children ages 6 to 11 years will be
recruited from Providence County, Rhode Island. Adult-child pairs will be randomized to: (1) financial incentive
only arm that will receive weekly $15 financial incentive coupons to subsidize purchase of healthy foods at a
local SEA grocery store; or (2) financial incentive plus twice-monthly, family-based group nutrition education at
the Center for SEA led by SEA community health workers; three motivational interviewing (MI) calls by trained
community health workers; dietary norms messaging for adults (via weekly text messages) and for children (via
Infographics at nutrition education sessions); and weekly $15 financial incentive coupons to subsidize
purchase of healthy foods at SEA grocery stores; or (3) an Academic Engagement attention control arm that
will follow the structure of the financial incentive plus nutrition education, MI and text messages and
infographics arm. The primary outcomes are study feasibility and clinically meaningful improvement in child’s
diet quality (measured by healthy eating index). Secondary outcomes are clinically meaningful changes in
children’s body mass (~ 2kg weight loss or no weight gain), HbA1c (0.5%) and parent’s diet quality, HbA1c and
the home food environment. These study findings will be used to inform a future, larger clinical trial.

Public health relevance
Project Narrative Relative to other racial/ethnic groups, Southeast Asian (SEA) children (specifically Hmong, Cambodian, Vietnamese and Laotian) experience higher rates of diet-related chronic diseases like type 2 diabetes risk factors. We will leverage our a longstanding partnership with the Center for SEA to test the feasibility and preliminary efficacy of an innovative multilevel, multicomponent, multigenerational dietary intervention with SEA families with children ages 6 to 11. This intervention integrates family-based nutrition education, motivational interviewing, descriptive dietary norms messaging, and healthy eating financial incentive coupons to improve children’s diet quality (primary) and body mass index and HbA1c (secondary).